Functional anaylses of the CDS48 and SLAMF8 receptors ........

Genetic studies have implicated the SLAM family in Systemic lupus erythematosus (SLE), but the functional roles of specific gene(s) within the SLAM locus in SLE are not yet clear. Our recent studies show that CD48 deficient (-/-) mice backcrossed onto the C57BL/6 (B6) background from the 129Sv background for 12 generations develop a lupus-like syndrome. By 6 months of age, these CD48-/- mice develop activated T and B cells, anti-nuclear antibodies, immune complexes and glomerulonephritis. We also have found that there are defects in T cell tolerance in CD48-/- mice. There are 2 potential explanations for the development of the SLE phenotype: Disease could be caused by the absence of CD48, or due to epistatic interactions between 129Sv genes flanking the disrupted CD48 gene and B6 genes in the CD48-/- mouse strain. The goal of Project 3 is to investigate the role of CD48 in SLE. As a definitive tool to understand the essential functions of CD48, we will use CD48-/- B6 mice generated by homologous recombination using B6 ES cells. Our specific aims are: 1) To test the hypothesis that CD48 regulates antigen-specific CD4 T cell activation and tolerance. We will examine if there are intrinsic T cell defects and/or dysregulated interactions between APC and T cells. We also use CD244-/- mice to investigate whether the CD48 ligand, CD244, regulates T cell responses. This focus on CD244 is driven by genetic studies of Project 1 that implicate CD244 variation in human SLE and preliminary data that suggest CD244 on the APC may regulate T cell: APC interactions. 2) To test the hypothesis that CD48 regulates B cell activation and/or B cell tolerance. We will determine if there are B cell intrinsic defects, examine humoral immune responses, and generate CD48-/- VH3H9 transgenic mice to study the role of CD48 in regulating anti-dsDNA B cells. 3) To investigate the hypothesis that CD48 regulates the development of SLE. We determine whether SLE develops in B6 CD48-/- mice. If SLElike disease develops, then we will evaluate the function of CD48 on the T cell, B cell and other cell types in SLE. If SLE does not develop, we will test the hypothesis that CD48-/-(129Sv x B6)BC12 CD48- /- mice develop SLE due to flanking 129Sv SLAM family genes and not due to the disrupted CD48 gene, by introducing a 129Sv BAG with a normal or disrupted 129Sv CD48 gene into the CD48-/- C57BL/6 mouse and assess whether the resulting strains develop SLE. This PPG facilitates collaborative interactions and provides a number of important tools and approaches that will enable us to address these important issues. These studies should contribute to the overall goal of this PPG: to understand how SLAM family members control pathways that regulate the development of SLE.